Single-Cell Transcriptome & Effect of Immune Checkpoint Therapy on Kaposi Sarcoma

Abstract – Single-Cell Transcriptome & Effect of Immune Checkpoint Therapy on Kaposi Sarcoma
Kaposi Sarcoma (KS) is a malignancy resulting from KS γ-herpresvirus (KSHV) infection occurring in
immunosuppressed individuals, as well as a disease occurring primarily in males in subSaharan Africa and
southern Mediterranean countries. The tumor is thought to arise from lymphatic endothelial cells, but it is
pathologically complex with an admixture of vascular-like slits, spindle cells, and infiltrating inflammatory cells.
KSHV is found in a subset of tumor cells with either lytic or latent gene expression profiles. Due to this complexity,
there is very limited information about genomic and transcriptomic characteristics of this malignancy. The
development of single cell (sc) transcriptomics (RNA-seq) provides a unique opportunity to identify key
characteristics that underlie the development of KS.
Treatment of KS involves local therapies, chemotherapy, angiogenesis or proteasome inhibitors, or
immunotherapies, such as immunomodulatory drugs (IMiDs) or immune checkpoint inhibitors. Recent findings
have suggested that KS responds to inhibitors of the programmed death-1(PD-1) pathway in approximately 20-
30% of individuals, but may rarely cause severe inflammatory KSHV-associated disorders. The current project
will take advantage of an expansion arm of our current trial of nivolumab in HIV-associated KS. We will select
samples before and after 2 months of nivolumab treatment from the 5 individuals with the best response and 5
individuals with progressive disease or no response to treatment. One goal of the current project is to identify
pre-treatment characteristics, using scRNA-seq, that predict response or progression of KS treatment with PD-
1 inhibitor, nivolumab. A second goal of this project is to determine what changes of cell composition and gene
expression occur with nivolumab in tumor cells and the tumor microenvironment. The aims are as follows:
Aim 1. Determine the effect of PD-1 checkpoint inhibitor therapy on lymphoid infiltration into KS tumors.
We will use scRNA-seq to enumerate B, CD4+ and CD8+ lymphocytes, natural killer, dendritic, and plasma cells,
macrophages, mesenchymal, endothelial, and other cells in samples before and after nivolumab treatment.
Aim 2. Determine the effect of PD-1 checkpoint inhibitor therapy on cellular and viral gene expression.
We will use scRNA-seq to quantify levels of expression of KSHV lytic and latent genes, as well as expression of
cellular genes in angiogenesis, proliferation, apoptosis, and metabolic pathways.

Public health relevance
Narrative – Single-Cell Transcriptome & Effect of Immune Checkpoint Therapy on Kaposi Sarcoma The current project uses samples from individuals before and after they respond to immune checkpoint inhibitor therapy or fail to respond to this treatment for single cell RNA sequence analysis. The short term benefit is obtaining an in-depth description of cells and their gene expression profiles in Kaposi sarcoma tumors. The long term benefit is defining predictive criteria of response to immune checkpoint inhibitor therapy.